Providing nicotine replacement therapy to enhance the efficacy of a smoking cessation smartphone app for Hispanic adults

PROJECT SUMMARY/ABSTRACT (DESCRIPTION)
Hispanic adults, the largest and fastest growing minority population in the United States (US), have
disproportionate smoking-related morbidity and mortality. They lack access to standard smoking cessation
treatments primarily due to the absence of medical insurance and guidance from healthcare providers to quit.
Compounding the access problem are systemic racism within healthcare and scientific communities, along with
a lack of value placed on conducting rigorous clinical research among Hispanic adults. Needed now is rigorous
research on methods to enable Hispanic adults to access efficacious evidence-based interventions to quit
smoking. Two widely available cessation methods that hold promise for Hispanic adults are: (1) smartphone
applications (“apps”) providing behavioral intervention, and (2) nicotine replacement pharmacotherapy (NRT).
Apps can be freely accessed and widely available, with 91% of Hispanic adults owning smartphones. iCanQuit,
based on Acceptance and Commitment Therapy, is the only app proven efficacious for smoking cessation in a
Phase III randomized trial (N = 2415). Among Hispanic participants (N = 220) in the parent iCanQuit trial,
results showed significantly higher self-reported 12-month 30-day point prevalence abstinence (PPA) rates for
iCanQuit participants compared to QuitGuide participants—an app that follows US Clinical Practice Guidelines
(34% iCanQuit vs. 20% QuitGuide; OR = 2.20; 95% CI: 1.10, 4.41, P = .02). Regarding medications, NRT has
high reach. While combining behavioral intervention with NRT generally results in higher quit rates than
behavioral intervention alone, existing evidence primarily stems from in-person clinical and telephone-based
trials focused on non-Hispanic adults. Although some research suggests underutilization of quit smoking
medications among Hispanic adults, our research indicates that providing free NRT improves its uptake. Most
pertinently, we found that Hispanic iCanQuit participants who used NRT on their own within 3 months post-
randomization showed descriptively higher self-reported 12-month 30-day PPA rates compared to non-users
(45.5% users vs. 28.8% non-users, OR = 2.24; 95% CI: 0.54, 9.27, P = .26). It is unknown whether providing
Hispanic adults with free NRT in combination with iCanQuit cost-effectively yields higher biochemically verified
quit rates than iCanQuit alone. Thus, in a fully-powered RCT, this proposal will: (1) determine whether
iCanQuit combined with free NRT (n = 427) has significantly higher biochemically verified 30-day PPA than
iCanQuit alone (n = 427) at 12 months post-randomization; (2) determine the cost-effectiveness of iCanQuit
plus NRT vs. iCanQuit alone, as measured by cost per quitter, cost per life year gained, and cost per quality-
adjusted life year (QALY) gained. We will also apply the RE-AIM dissemination framework and conduct
qualitative research on the barriers and facilitators to dissemination of each intervention to Hispanic adults
nationwide. This rigorous trial will determine whether providing iCanQuit alone is sufficient or whether adding
NRT cost-effectively yields higher quit rates for Hispanic adults who smoke.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT The overall aim of this project is to determine whether providing iCanQuit alone is sufficient or whether adding nicotine replacement therapy cost-effectively yields higher biochemically verified quit rates for Hispanic adults who smoke. With the potential to identify a highly disseminable intervention, results could have broad public health impact for Hispanic adults nationwide.